Rapid Sample-to-Answer Diagnosis of Kaposi's Sarcoma Across Sub-Saharan Africa using KS-COMPLETE

Abstract
In this proposal, we will develop, manufacture, and perform a multi-site sub-Saharan African clinical
validation of KS-COMPLETE — the first true point-of-care sample-to-answer diagnostic system for
Kaposi's sarcoma (KS). Our recent large-scale studies in Africa have shown that KS can be diagnosed through
quantification of Kaposi's sarcoma herpesvirus (KSHV) DNA in a skin biopsy with high sensitivity and specificity.
These efforts have also resulted in the development of TINY — a robust, easy-to-use, infrastructure-free, point-
of-care (PoC) technology for KSHV DNA quantification — which is being currently deployed in a multi-site
evaluation. The work has also revealed that the key challenge to widespread adoption of skin biopsy-based PoC
systems is the time and manual steps required to extract DNA from a skin biopsy — which can be up to 4 hours.
KS-COMPLETE will be the first “direct-to-LAMP” diagnostic system for skin punch biopsies. Similar
direct-to-LAMP methods have greatly simplified PoC diagnostics for other sample matrices but the solid-phase,
collagenous nature of skin has made this a challenge for biopsies. KS-COMPLETE will address this issue with
our “SLICER” technology that will automatically process a punch biopsy into smaller “micro-cores” on which we
can directly perform DNA quantification in TINY through our “direct-to-LAMP” approach. This approach will
reduce the time to result to around 60 minutes, eliminate all the current manual and intensive sample processing
steps, and is compatible with cost, robustness, infrastructure, and simplicity requirements for operation in LMICs.
Clinical validation of the system will be done through our established network of KS clinical sites in Africa. By
the end of the project, we will deliver 12 KS-Complete systems and conduct a multi-site clinical validation.
KS is one of the most common cancers in men and women in sub-Saharan Africa. KS is difficult to distinguish
from other skin conditions, particularly in Africa where access to trained pathologists is limited and
immunohistochemistry is practically non-existent. Early-stage and more accurate diagnosis would confer many
clinical benefits. For patients who have KS, it obviates the need for the difficult to obtain, slow, and unreliable
histopathology and allows for detection at earlier clinical stages resulting in better clinical outcomes. For patients
with mimickers, rapid exclusion of KS allows for timely re-orienting of the diagnostic process and prevents use
of potentially toxic chemotherapy. Our direct-to-LAMP diagnostic test could have significant impact beyond the
diagnosis of KS as multiple other viral, mycobacterial and fungal-related skin diseases currently diagnosed
through traditional pathology could be transitioned to this method and ultimately the point of care.

Public health relevance
Narrative Kaposi's sarcoma (KS) is one of the most common cancers in sub-Saharan Africa, and, like other tumors, early detection can lead to improved survival. We propose to develop, manufacture, and perform a multi-site sub-Saharan African clinical validation of KS-COMPLETE – the first true sample-to-answer diagnostic system for Kaposi's Sarcoma (KS). This system will enable physicians to diagnose KS at the point-of-care in less than 60 minutes – compared with the 2 weeks traditional pathology often requires – significantly improving patient outcomes.